A novel metabolic reprograming strategy for the treatment of diabetes-associated breast cancer

PROJECT SUMMARY/ABSTRACT
Diabetes increases the risk of breast cancer (BC) in women and mortality in patients with cancer. African-
American (AA) women are disproportionately affected by diabetes and its complications. Concurrently, these
women have worst outcome from BC. In addition, many women gain weight after BC treatment and end up with
diabetes. AA and Hispanic/Latina women are even more affected by this. There exist some important distinctions
between the BC patients with and without diabetes in the regimen selection and outcomes of cancer therapy.
Currently there are no specific treatments to target diabetes-associated BC. Our long-term goals are to
understand the fundamental mechanisms of diabetes-induced BC progression, and to develop personalized
treatments for diabetes-associated BC. Based on the metabolic differences between normal and cancer cells,
we for the first time propose this safe and effective therapeutic strategy targeting cancer metabolism to “poison”
BC cells, with relatively non-toxicity to normal cells. The present project focuses on targeting lactate metabolism
and transport to induce BC cell death. The central hypothesis of this strategy is that pharmaceutical induction of
glucose import and glycolysis to even higher levels while blocking the products of glycolysis from entering the
tricarboxylic acid (TCA) cycle, results in production of high amounts of lactate. Meanwhile, blocking the export
of excessive lactate by inhibiting monocarboxylate transporter 4 (MCT4) leads to a metabolic crisis and
acidification within the cancer cells, causing their death. Our preliminary in vitro results indicate that this metabolic
reprogramming strategy (MRS) can successfully block cancer cells proliferation. Moreover, we have identified
CB-2 as a novel small molecule MCT4 inhibitor (Patent Application Number: 62/662,637). CB-2 has shown a
significantly inhibitory effect on lactate secretion and striking cytotoxic activity against triple-negative breast
cancer (TNBC) cells, which have a high glycolytic rate/MCT4 expression. Guided by strong preliminary data,
we propose to pursue three Specific Aims to test this hypothesis: (1) To investigate the effect of MRS on
energy metabolic pathways of different BC cell lines and the possible reasons for sensitivity or resistance to this
approach. (2) To confirm the mechanism of action and anticancer activity of CB-2. (3) To test the effectiveness,
safety, and potential side effects of this MRS in diabetic mouse models bearing human BC xenografts.
Collectively, these studies will allow us to gain a more in-depth understanding of cancer cell metabolism and
may in the long term reveal an effective therapeutic strategy for diabetes-associated BC and TNBCs. The
complex biology that contributes to the unequal cancer burdens needs to be investigated to increase our basic
understanding of cancer health disparities. Hence, investigating glucose metabolism features in tumor cells
would be a significant step in shedding light on this health disparity. Moreover, searching new drug targets and
developing new treatment methods in diabetes-associated BC contribute to decreasing cancer health disparities.

Public health relevance
PROJECT NARRATIVE Diabetes mellitus may dramatically increase risk of breast cancer (BC) and mortality in patients with cancer. Our proposed studies aim to understand the fundamental mechanisms of diabetes-induced BC progression, and to develop personalized treatments for diabetes-associated BC. This research will allow us to gain a more in- depth understanding of cancer cell metabolism and reveal an effective therapeutic strategy for diabetes- associated BC and triple-negative breast cancer (TNBC), which may contribute to reducing cancer health disparities.